Project 4 - Mechanisms of pyrophosphate dysregulation

PROJECT 4 SUMMARY
Mechanisms of pyrophosphate dysregulation. Hydroxyapatite deposition in bones and teeth is a carefully
orchestrated biochemical process aimed at balancing the concentrations of inorganic pyrophosphate (PPi), a
potent calcification inhibitor, and the local concentrations of phosphate (Pi), a calcification promoter, to
establish a proper PPi/Pi ratio to enable regulated tissue mineralization to take place. While we have a good
understanding of what molecules control physiological skeletal and dental mineralization, limited data exists as
to whether alterations in those same mechanisms lead to ectopic calcification in the eyes, brain, and
vasculature in diseases of aging such as age-related macular degeneration (AMD), Alzheimer's disease (AD)
and atherosclerosis. AMD is clinically characterized by the presence of extracellular deposits known as drusen,
located between the retinal pigment epithelium (RPE) and the choroidal microvasculature in the area known as
the Bruch’s membrane in the macular region. Drusen is also observed in the normal aging eye associated with
local inflammation, and the presence of a high number of large drusen in the macular region is a significant risk
factor for developing AMD. While there are no murine models that fully reflect the pathophysiology of human
AMD, the Abcc6-/- and the Enpp1-/- mouse models of pseudoxanthoma elasticum (PXE) and generalized
arterial calcification of infancy (GACI) respectively, manifest not only vascular and brain calcification but also
calcifications in the eyes and therefore these mouse models can be used as surrogates to understand drusen
formation. In this PO1 component we will test the overarching hypothesis that dysregulation of the PPi/Pi ratio
underlies the pathophysiology of ectopic calcification in diseases of aging, focusing our studies primarily on
eye calcification. Given that tissue-nonspecific alkaline phosphatase (TNAP) is the major pyrophosphatase
controlling the PPi/Pi ratio, TNAP may be a useful druggable target for the prevention/amelioration of drusen
formation. Thus, the goals of this Project 4, designed to be mutually supportive with the other PO1
components, are to probe the causative role of PPi dysregulation in eye calcification by genetically
manipulating the production and degradation of PPi in vivo. We will investigate if the PPi/Pi ratio is being
controlled (either in the choroid endothelium, RPE cells or both compartments) via the production and function
of a special type of extracellular vesicles known as matrix vesicles (MVs), where hydroxyapatite starts to form
during physiological skeletal/dental mineralization, or if this ratio is controlled via the pathophysiological
upregulation of TNAP activity alone. We will also conduct pharmacological proof-of-concept studies aimed at
affecting calcification in the eye via modulating the production and degradation of systemic and local PPi
concentrations. Completion of these studies, within the context of this multi-disciplinary team effort, will lead to
novel insights into the interrelated pathophysiology of AMD, AD and vascular calcification and will validate a
druggable pathway to address the unmet clinical need of treating/preventing ectopic calcification manifesting in
these highly prevalent diseases of aging.